EFFECTS OF APOPROTEIN E ON POSTPRANDIAL LIPEMIA

Examine whether ApoE polymorphism influences the magnitude of postprandial rise in triglyceride rich lipoproteins and their composition with regard to cholesterol content and ApoE lipoprotein distribution.